Maladaptive antiviral pathways in Alzheimer's disease

ABSTRACT
Alzheimer's disease (AD) is the most common form of late-onset dementia. The extents of tau pathology are
closely related to memory decline. How pathogenic tau causes cognitive deficits is not clear. While most
studies on tau have been focused on direct effects of tau on neurons, compelling human genetic studies linked
maladaptive innate immune responses, including microglial responses, to elevated risk of developing late-
onset Alzheimer disease. The striking enrichment of innate immune genes as risk alleles for Alzheimer
disease supports critical disease-enhancing role of maladaptive microglia in tau-mediated cognitive deficits.
Identifying how maladaptive microglial enhances tau toxicity could lead to new therapeutic strategies. In our
preliminary studies, we found that tauopathy mice exhibit hyperactive Cyclic GMP-AMP synthase (cGAS)-
Stimulator of interferon genes (STING) signaling. As a major sensor of cytosolic DNA, cGAS-STING pathway
mobilizes antiviral responses via activation of interferon regulatory factors (IRFs) and expression of cytokine
and type I interferon genes. The hyperactive cGAS pathways contributes to tau toxicity since genetic reduction
of cGAS protected against tau-mediated spatial learning and memory deficits in a tauopathy mouse model of
Alzheimer disease. In addition, the protective effects were associated with reduced interferon-enriched
microglial subpopulations and reprogramming of disease-associated microglial states as identified using single
nuclei RNA-seq. We hypothesize that microglial cGAS-STING hyperactivation mediates the maladaptive
disease-enhancing microglial response in tauopathy. To test this hypothesis, In Aim 1, we will first determine
how cGAS activation in microglia enhances tau toxicity (1a). Using a combination of single nuclei RNA-seq,
pathological and functional analyses, we will investigate if toxicity from cGAS hyperactivation in microglia or
bone marrow-derived monocytes (1b, 1c). In Aim 2, we will dissect if the toxic effects of cGAS activation in
tauopathy are mediated by STING-dependent or -independent mechanisms, we will determine if loss of STING
phenocopies the effects of cGAS inactivation on tau toxicity and transcriptomic changes (2a). We will then
determine STING-independent mechanisms of cGAS activation by assessing how cGAS inactivation affects
tau toxicity on Sting null background (2b). The significant protective effects of partial loss of cGAS supports that
partial inhibition with pharmacological inhibitors of cGAS could be beneficial for tauopathy. We showed that a
specific cGAS inhibitor, TDI6570, is brain permeable and effectively inhibit expression of type 1 interferon
target genes in tauopathy mice. We will then optimize the dosing using formulated chow based on PK/PD, and
evaluate the beneficial effects of the cGAS inhibitor before or after the onset of cognitive deficit in tauopathy
mice in Aim 3. Completion of the proposed study will identify novel disease-enhancing properties of innate
immune responses in AD, and provide new therapeutic direction for pharmacological intervention.

Public health relevance
PROJECT NARRATIVE This project aims at investigating mechanisms underlying maladaptive immune responses in tauopathy models of Alzheimer's disease. This study may provide new therapeutic avenue for treating this devastating disease.